Defining high-risk genomic groups of Stenotrophomonas maltophilia

ABSTRACT
Stenotrophomonas maltophilia is an environmental, aerobic, non-fermentative Gram-negative bacterium that is
increasingly recognized as an important cause of healthcare-associated infections. It is intrinsically resistant to
most β-lactam agents including carbapenems that are the last-resort, broad-spectrum agents for difficult-to-treat
bacterial infections and is now among the most frequently isolated carbapenem-resistant Gram-negative bacteria.
S. maltophilia has generally been perceived as a low virulence pathogen that colonizes the respiratory tract of
acutely or chronically ill patients. At the same time, some patients develop serious infections such as bacteremia
or pneumonia due to S. maltophilia and do not survive them. This dichotomy may be partially explained by host
factors including underlying medical conditions and acuity of illness at the time of infection; however, much less
is known about strain factors of S. maltophilia that may impact clinical presentation and patient outcomes. In a
recent, prospective, multicenter clinical/genomic cohort study of S. maltophilia conducted at hospitals in Japan,
all strains belonged to the genus Stenotrophomonas by whole genome sequencing, but only a third were
identified as S. maltophilia sensu stricto. Other strains belonged to various Stenotrophomonas genomic groups
that were spread across the hospitals. We observed several genomic groups associated with high infection rates,
including S. pavanii, S. muris, S. maltophilia genomic group 7 and a distinct genomic subgroup of S. maltophilia.
These potential high-risk genomic groups were also more commonly associated with bloodstream infection and
higher 30-day mortality rates. These findings led us to hypothesize that S. maltophilia consists of diverse genomic
groups including previously unrecognized groups, and that specific genomic groups within the S. maltophilia
complex are more likely to cause infections and adverse patient outcomes than others. In this project, by
leveraging an established network of US hospitals for studying drug-resistant pathogens and infections, we will
prospectively collect the demographic, clinical and microbiological data of patients with a S. maltophilia clinical
culture at six large hospital systems to facilitate rigorous discrimination of infection or colonization, and
determination of clinical outcome, with the goal of linking genomic groups with infection and outcomes, and
characterizing phenotypic features of each genomic group. We will then compare virulence in in vivo infection
models and develop a PCR assay to rapidly identify major genomic groups. The ability to predict the risk of
adverse clinical outcomes based on specific genomic group has the potential to transform the approach to
patients at risk of S. maltophilia complex infection and optimize their management.

Public health relevance
PROJECT NARRATIVE Stenotrophomonas maltophilia is a multidrug-resistant bacterial pathogen that is increasingly causing difficult-to- treat infections in hospitals. The project will determine which groups of strains are more likely to cause infection and death by linking patient outcomes with strain groups and test the pathogenicity of these strains in models of infection.